Career Enhancement Program

CAREER ENHANCEMENT PROGRAM: PROJECT SUMMARY
The Career Enhancement Program (CEP) of the Ovarian Cancer SPORE intends to attract and stimulate new
investigators, including women, minorities, and individuals with disabilities to carry out translational research
related to ovarian cancer and provide mentorship. The program director, Dr. Burger, and the co-director, Dr.
Shih, will solicit applications and coordinate selection process. Candidates submit an application and are
evaluated through a careful selection process involving a career enhancement committee as well as the
SPORE steering committee. The recipients will be required to present their progress twice a year and submit
annual progress report subject to the aforementioned review process. In addition to the requested funding
($50,000) from the SPORE program, a total annual matching fund of $150,000 will be provided by the Sidney
Kimmel Comprehensive Cancer Center at Johns Hopkins and the Department of Gynecology/Obstetrics at
University of Pennsylvania. Those supports allow us to fund 2-3 career awards at funding levels of $50,000 to
$100,000 each year. It is expected that the CEP will play an important role in the recruitment and development
of a cadre of outstanding translational scientists and future leaders in the ovarian cancer research field. At the
same time, these new investigators will bring their own unique expertise and innovations to this Ovarian
Cancer SPORE program.
Specific Goals
• To attract, select, and mentor promising new investigators with a special emphasis on recruiting
qualified women, minorities, and individuals with disabilities.
• To develop and support the awardee's rigorous and innovative translational research projects focusing
on various topics related to ovarian cancer.

Public health relevance
CAREER ENHANCEMENT PROGRAM: PROJECT NARRATIVE The CEP is intended to fulfill the overall goal of the SPORE program by recruiting the best junior faculty members and by fostering the career growth of mid-career or senior faculties to focus on translational ovarian cancer research.